Role of Prefrontal Cortical Projections to the Midbrain in Alcohol-Induced Cognitive Deficits in Mice

Project Summary and Abstract
Alcohol Use Disorder (AUD) impacts upwards of 15 million Americans in the United States and has many
consequences on overall health and quality of life for people affected by this disorder. Despite this, only around
seven percent of people with AUD seek treatment and options for care remain limited, creating an urgent need
for more research into the development and treatment of AUD. A major source of interest lies in what factors
predispose certain individuals who consume alcohol over others to develop AUD, which can provide insight
into specific preventative and treatment measures for this population. Deficits in cognitive domains of response
inhibition and cognitive flexibility have been implicated as risk factors for later development of AUD and are
predictors of more severe alcohol induced cognitive dysfunction. The medial prefrontal cortex (mPFC) is at the
center of the brain circuitry that mediates aspects of cognitive function known to be impaired in AUD and
studying the underlying neural pathways impacted by alcohol exposure has been a major area of study in the
field. Human neuroimaging studies have identified mPFC projecting neurons to ventral tegmental area (VTA)
as an important circuit in reward processing and initiation of goal directed behavior as well as alcohol craving in
AUD models. The aim of this proposal is to utilize cutting edge techniques in single cell in vivo calcium imaging
and behavioral tasks in mice to understand the contribution of this important but understudied pathway to
preexisting and alcohol-induced deficits in cognitive function. Using complex operant positive reinforcement
behavioral paradigms to test domains of cognitive flexibility and response inhibition in mice combined with
single cell in vivo calcium imaging dynamics of mPFC→VTA projections as mice complete the task, I will study
how this pathway responds to and changes as mice learn before and after alcohol exposure. I will first study
whether there are individual differences in cognitive function in response inhibition and cognitive flexibility in
mice at baseline with an operant behavioral task, after which I will characterize the activity pattern of
mPFC→VTA projecting neurons using head mounted microendoscopes to capture real time neuronal activity
of these projections in the mPFC in freely behaving mice as they learn the tasks. Further, using longitudinal
tracking analysis, I will determine if there are individual differences in activity patterns between mice with
variations in baseline cognitive function and how these changes evolve after binge drinking alcohol exposure in
a two-bottle choice task. Completion of this proposal will provide valuable insight into the circuit level changes
that underlie individual differences in vulnerability to alcohol induced cognitive deficits and will provide
invaluable training for me as a future independent academic researcher.

Public health relevance
Project Narrative The medial prefrontal cortex governs many aspects of cognitive control and is hypothesized to play a major role in individual differences in cognitive function both before and after alcohol exposure that drive maladaptive behaviors that characterize alcohol use disorder (AUD). The focus of this proposal is to gain insight into the contribution of a population of prefrontal cortical neurons that project to the midbrain in preexisting and alcohol induced cognitive dysfunction in order to understand more about this specific pathway in the vulnerability of AUD development. This research addresses a critical gap in knowledge regarding the cognitive factors that predispose certain individuals over others to AUD development.